Mechanistic Basis of Resistance to Chemohormonal Treatment in Prostate Cancer

PROJECT SUMMARY
In 2019, prostate cancer will be diagnosed in an estimated 174,650 men, and account for 31,620 deaths,
second only to lung cancer in terms of mortality for men. While local and regional disease typically carries an
excellent prognosis, prostate cancer is a heterogeneous and diverse disease that includes both indolent and
aggressive phenotypes. Androgen deprivation therapy (ADT) was the first successful treatment for men with
advanced metastatic prostate cancer more than 50 years ago, and it remains a cornerstone of treatment today,
but not all men will respond to ADT. The use of chemotherapy in combination with ADT significantly improved
upon ADT alone in terms of overall survival. Unfortunately, despite these advances, a significant portion of
men are resistance to combination chemohormonal therapy. The long-term goal of this proposal is to enable
more effective treatments for men with prostate cancer. This application proposes to address this goal by
investigating the mechanistic basis for chemohormonal resistance in prostate cancer using in vitro cellular
studies, in vivo murine models, and retrospective patient data.
Our laboratory has identified Paired-Related Homeobox Protein 2 (PRRX2) as contributing to ADT resistance
in vitro. Interestingly, PRRX2 is known to promote an epithelial to mesenchymal transition (EMT), which is
associated with chemoresistance in prostate cancer. However, the role of PRRX2-driven EMT has not been
investigated in the context of chemohormonal resistance. Therefore, my central hypothesis is that a PRRX2-
driven increase in EMT causes chemohormonal treatment resistance in prostate cancer. To test my
hypothesis, with Aim 1 I will determine the contribution of PRRX2 to EMT and chemohormonal resistance
using in vitro models of prostate cancer. In Aim 2, I will use in vivo mouse models determine the sufficiency of
PRRX2-driven EMT for chemohormonal resistance. Finally, in Aim 3, I will evaluate the clinical relevance of
my results by developing a gene signature of PRRX2-driven EMTness, and determining its association to
clinical features of prostate cancer using patient data. Together, these aims will fill a fundamental gap in the
understanding of prostate cancer pathogenesis, and allow for more effective treatments to be developed. I will
carry out these experiments under the mentorship of my sponsor, Dr. Sarki Abdulkadir, with his extensive
expertise in prostate cancer research. Dr. Abdulkadir will provide all of the necessary equipment and facilities,
and access to the core facilities of Northwestern University. The training plan set out by Dr. Abdulkadir will train
me as an independent researcher, while also maintaining my clinical skills to prepare me exceptionally well for
the next steps of my training as a physician scientist.

Public health relevance
PROJECT NARRATIVE Prostate cancer is the most common cause of cancer and the second most common cause of cancer-related mortality for men in the United States. The goal of this proposal is to enable more effective treatment of prostate cancer by understanding the mechanistic basis for resistance to chemohormonal therapy. This will not only contribute to our fundamental knowledge of prostate cancer pathogenesis, but also empower the development of strategies to improve treatments for men with prostate cancer.